Impact of Physical Activity Routines and Dietary Intake on the Longitudinal Symptom Experience of the people living with HIV (PROSPER-HIV)

Project Summary/Abstract:
People living with HIV (PLHIV) experience a disproportionately high symptom burden (e.g., fatigue, insomnia,
pain) with few treatment options. These symptoms are frequent, distressing, often co-occur, and have
significant consequences on the health and well-being of PLHIV, yet we know almost nothing about how to
effectively mitigate them. Non-pharmacological treatment options are highly desirable for symptom
management among PLHIV who already experience a high pill burden from multiple comorbid diseases. Our
team previously reported that physical activity and better nutrition were associated with lower symptom
intensity in PLHIV; but a clearer understanding of the effects of physical activity and diet is required to
determine how these approaches can reduce symptom distress in this population. Building on these data, this
project proposes to examine the effect of two promising non-pharmacological strategies, Physical Activity
Routines And Dietary Intake, on the longitudinal Symptom Experience of PLHIV (PARADISE-HIV).
The PARADISE-HIV study is an observational, longitudinal study that will utilize the substantial
infrastructure of the Centers for AIDS Research (CFAR) Network of Integrated Clinical Systems (CNICS) to
examine physical activity and dietary patterns and symptom burden of 850 PLHIV over four years. This study
will occur in four demographically diverse HIV clinics [Case Western Reserve University (Cleveland, Ohio),
University of Alabama at Birmingham (Birmingham, Alabama), University of Washington (Seattle, Washington)
and Fenway Health Institute (Boston, Massachusetts)]. PARADISE-HIV will overcome the limitations of
previous studies by 1) enrolling a large, demographically and geographically diverse, clinic-based sample of
PLHIV, 2) examining the relationship between physical activity, dietary intake and symptom burden over time,
and 3) using prospective, gold-standard measures of physical activity (i.e., triaxial accelerometry) and dietary
intake (i.e., 24-hour diet recalls). Anthropomorphic and physical fitness factors will be assessed as potential
mediators of physical activity and dietary intake on symptom burden and intensity. When our aims are
accomplished we will have precise, definitive, high-quality data describing the impact of physical
activity and diet on symptoms in PLHIV.
These data can be used clinically to provide feedback to HIV health care providers on the physical
activity and dietary intake of their patients. The PARADISE-HIV study will also have a significant scientific
impact and will inform the next phase of this program of research. These findings will be used to develop an
individually-targeted, clinic-based intervention to improve physical activity and dietary intake that will eventually
reduce symptoms among PLHIV. They will also be used to examine biological and clinical mechanisms that
lead to the prevalent unremitting symptoms experienced by PLHIV. Thus, the proposed study is likely to
stimulate novel research that will have a long-term impact on the health and quality of life of PLHIV.

Public health relevance
Project Narrative: Strategies to reduce the high symptom distress among people living with HIV (PLHIV) are urgently needed. Our study examines how two promising symptom management strategies, physical activity and good dietary intake, impact symptom burden and intensity among PLHIV over time. These strategies can be incorporated into ongoing health promotion initiatives in HIV specialty clinics nationwide.